Machine Learning for CCHD Screening using Dynamic Data

PROJECT SUMMARY/ABSTRACT
I propose to develop and test a machine learning (ML) algorithm that uses dynamic data from pulse
oximetry for critical congenital heart disease (CCHD) screening. Oxygen saturation (SpO2)-based screening is
the current standard for CCHD screening; however, it fails to detect 50% of asymptomatic newborns with
CCHD or nearly 900 newborns in the United States annually. Most newborns missed by SpO2 screening have
defects with systemic obstruction, such as coarctation of the aorta (CoA), that do not cause hypoxemia. Pulse
oximetry can also measure non-invasive measurements such as perfusion such as perfusion index (PIx),
radiofemoral delay, heart rate, and other waveform characteristics. Introduction of other pulse oximetry
features is expected to improve CCHD and CoA detection. My recent work revealed improved CCHD detection
using ML algorithms that combined pulse oximetry features. The algorithms improved CCHD detection to at
least 93%, including improved detection of CoA, while maintaining high specificity. However, the model
depended on two separate measurements including simultaneously artifact free waveforms in both the right
hand and a foot. Having a model with dynamic prognostication that allows for an infant’s predicted outcome to
change as new data is incorporated could be better. Additionally, the amount of time to obtain two waveforms
that are artifact free in a possibly moving baby needs to be understood for implementation.
Therefore, I will develop and test a ML algorithm that combines pulse oximetry features and
incorporates dynamic data from repeated measurements allowing a newborn’s predicted classification (CCHD
vs no-CCHD) to change as new data is incorporated. I will do this in two ways. The first will utilize only
inpatient measurements and will externally validate our recently developed ML algorithm. This first approach
will also test a “repeat” screen for any initial “fails,” an approach that mimics the current SpO2 standard screen
and is expected to keep the false positive rate below 1%. The second approach will incorporate measurements
after 48 hours of age (including from the outpatient setting). Outpatient CCHD screening has not been studied.
Most newborns are seen for routine follow up outpatient around the age at which CoA becomes more
clinically apparent, and thus, more likely to be detected by non-invasive perfusion assessments.
This study is significant because a dynamic screening model that includes perfusion data could save the
lives of hundreds of newborns with CCHD that are not diagnosed by SpO2 screening annually. Additionally, it
is innovative because it makes use of readily available non-invasive pulse oximetry data and will use dynamic
data (inpatient and outpatient) that allows for a newborn’s prognostication to change as new data is
incorporated. From this study and career plan, I will gain skills in machine learning with emphasis in dynamic
approaches, and implementation science. I will use the results and skills from this proposal to then study a
cluster randomized trial of our algorithm and assess implementation processes.

Public health relevance
PROJECT NARRATIVE Congenital heart disease is the most common birth defect and can be missed during pregnancy scan and newborn exam leading to delayed detection, poor outcomes, and death. This application seeks to test and develop a critical congenital heart disease screening machine learning algorithm that combines the current screening standard, oxygen saturation, with additional features to assess blood flow and perfusion and incorporates dynamic data from both inpatient and outpatient settings. This approach has the potential to increase infant survival and will develop neonatal specific devices using artificial intelligence driven diagnostics, which are priorities to the NICHD Pregnancy and Perinatology Branch and Obstetric and Pediatric Pharmacology and Therapeutics Branch.